Reagents for Chemical Oligophosphorylation, Synthesis of Oligophosphate-Organic Molecule Conjugates, and Biochemical Studies

Phosphorylated biomolecules play essential roles in human physiology, health, and medicine. Biological tar-
gets for phosphorylation include nucleosides, lipids, amino acids, peptides, and proteins. It has been discovered
recently that polyphosphorylation of proteins is an important post-translational modification, spurring researchers
to synthesize chemical probes containing oligophosphate chains of specific lengths as tools to explore what has
been termed the human polyP-ome. This development exposes the need for well-defined chemical reagents to
enable phosphate chains of a desired length to be conjugated to an organic molecule of interest. Recently we
reported the first well defined, crystalline reagent for the triphosphorylation of C, N, and O nucleophiles. This
was obtained by activation of trimetaphosphate using a modern peptide coupling reagent, and now we propose to
extend the methodology to afford new reagents for tetra-, penta-, and hexa-phosphorylation of C, N, and O nucle-
ophiles; this is what we term our class I family of reagents for oligophosphorylation of organic molecules. We also
propose to develop a class II family of reagents that is derived from the class I family by oligophosphorylation
of the classic Wittig reagent, H2CPPh3. The class II family of reagents opens up the possibility to make the con-
nection between an oligophosphate and a desired aldehyde-containing organic molecule via the Wittig reaction;
in this case the constructs so obtained will contain a non-hydrolyzable P–C bond next to the new olefinic junction
between the oligophosphate and the organic substrate. When using either the class I or II reagents to make the
connection between an organic molecule and an oligophosphate chain, the initially formed product will contain an
intact cyclophosphate residue. We propose to isolate and characterize such intermediates. Some of these will be
stable under physiological conditions and will be targeted for further study. We will study the ring-opening of the
cyclic intermediates by a variety of nucleophiles; use of hydroxide will give simply a terminal phosphate group at
the end of the oligophosphate chain, while other nucleophiles are expected to result in target constructs that may
contain linkages to two different organic residues at either end of the linear oligophosphate chain. In collabora-
tion with the Raines group (MIT Chemistry) we propose to undertake collaborative biochemical studies of bovine
pancreatic ribonuclease A (RNase A) inhibition by oligophosphates and their organic-molecule conjugates. Small
molecule ribonuclease inhibitors are valuable biochemical tools for studies of RNA for which success often relies
on shutting down all ribonucleolytic activity. Also in collaboration with Raines we propose to map out via protein
crystallography the binding mode for oligophosphates and their organic conjugates in the RNase A active site, to
aid in the iterative design of improved inhibitors.

Public health relevance
Phosphorylated biomolecules are key players in a variety of cellular processes and enzymatic pathways relevant to human health with applications including pharmaceuticals and diagnostics. This proposal seeks to develop two novel classes of reagents for chemical oligophosphorylation of organic molecules to deliver biologically relevant synthetic targets for chemical and biological studies. Also proposed in this application are collaborative studies to produce new organic molecule-oligophosphate conjugates as small molecule ribonuclease inhibitors, which are valuable biochemical tools for studies requiring manipulation of intact RNA molecules.